Evaluation Core (EC)

PROJECT SUMMARY/ABSTRACT
The Evaluation Core (EC) proposal outlines its contributions to the overall aims of the Coordination and
Evaluation Center at UCLA (CEC), as part of the overall NIH Diversity Program Consortium (DPC) and its goal
of enhancing the diversity of the NIH-funded workforce. In collaboration with the other CEC cores, and DPC
grantees, the EC is responsible for the consortium-level evaluation of the short, medium, and long-term
outcomes of BUILD grantee programs across student, faculty, and institutional levels, and of previously funded
NRMN components on medium and long-term outcomes. The EC continues to update DPC-approved
Hallmarks of Success and refine the Consortium-wide evaluation plan to guide our work. Our multi-method
evaluation builds on multiple case studies, cross-site analysis, a robust quasi-experimental design using
multilevel statistical analysis, and trend analyses of key quantitative indicators. For individual-level data on
BUILD participants, we integrate information from the Higher Education Research Institute (HERI) surveys of
freshman and senior students and of faculty nationally, CEC annual surveys of BUILD sites, event-level
“tracker” data about program participation, institutional record (IR) and national IPEDS data. We use this rich
set of data to compare the achievement of Hallmarks for BUILD participants with nonparticipants at the same
institution, across BUILD institutions, and between BUILD and non-BUILD institutions. The longitudinal dataset
and extensive covariates improve our ability to attribute causality to the interventions. National institutional
level data covering multiple years from IPEDS supports analysis of potential institutional-level changes by
comparing trends at BUILD versus similar non-BUILD sites. For NRMN, we draw on baseline data collected by
NRMN from participants and supplement it with CEC annual surveys to assess the long-term outcomes of
Hallmarks, comparing the statistically adjusted achievements of Hallmarks by specific program participants
versus those in the NRMN database who did not participate in the particular program. Innovative aspects of
our evaluation design include: (i) access and flexibility to build on established metrics in HERI national surveys
of undergraduate education, (ii) use of social network analysis to better characterize the outcomes of career
development strategies, and (iii) the analysis of BUILD programs across multiple institutions to provide the
statistical power to disaggregate the outcomes of specific intervention components and identify differential
effects on subpopulations, including program participants from underrepresented groups. Jointly with the DCC,
the EC will support any needed updates to data collection tools and processes, Hallmarks, and analytic
approaches to ensure the comprehensive assessment of the impact of BUILD (Phase 1 & 2) and NRMN
(Phase 1) activities. The EC will also contribute to the CEC's development and dissemination of new education
and training tools for use by BUILD and NRMN awardees and others from outside the DPC.